Research Pharmacy

The Research Pharmacy Core has a well-developed system for the monitoring, coordination, and support of research pharmacy activities at DF/HCC member institutions. This facility has been approved and funded by the CCSG since 2004, when it received excellent merit. The Core assures consistency in policies across the sites (including policies relating to the receipt, storage, formulation, and dispensation of investigational agents), facilitates best practices, and monitors perfonnance through a quality assurance program coordinated through the inter-institutional Research Pharmacy Core Committee. The Research Pharmacy participates in the DF/HCC Scientific Review and Monitoring Committees (PRMS) and Data and Safety Monitoring (DSM) program, as well as other relevant Cancer Center clinical trials oversight, monitoring, and policy initiatives.

Public health relevance
RELEVANCE (See instructions): The Research Pharmacy enables DF/HCC clinical investigators to conduct cancer-relevant research with a minimum of organizational encumbrances and differences in practice. The Research Pharmacy serves as a central point for the unification and integration of research-related pharmacy activities, fostering a coordinated clinical trials program within a multi-institution Comprehensive Cancer Center.